Phase II- Repurposing CRH antagonists for the treatment of endometriosis

PROJECT SUMMARY
The main goal of this Phase II SBIR project is to de-risk and advance the development of an oral therapeutic
that is intended to medically manage both the progression of endometriosis and the pain associated with it. This
could result in a reduction or elimination of the need for repeated surgical interventions. Endometriosis affects
approximately 10% of women globally and is a signiﬁcant cause of infertility and chronic debilitating pain in
women and teenagers. Unfortunately, there is no cure for this widespread condition, which often takes 6 to 10
years to diagnose. Currently, available treatments, such as hormone therapy, pain management, or surgery, do
not adequately address disease progression. They often come with undesirable side effects or fail to provide
lasting relief. Surgeries may not prevent the recurrence of the disease, leading women to undergo multiple
surgical procedures during their reproductive years. All current hormonal medications to treat endometriosis
negatively affect fertility. Our STTR Phase I results indicated that Sur180 Therapeutics' drug candidate
signiﬁcantly reduced pain and markers of proliferation. It also provided lasting protection after treatment had
stopped in a well-validated rat model of endometriosis without disrupting the estrous cycle. Sur180 Therapeutics
plans to reposition its drug candidate, protected by a new method-of-use patent recognizing its paracrine role in
the reproductive system. In Phase II, our team will further assess the drug's impact on reproductive health and
identify the lowest effective dose and dosing schedule to directly inform future clinical trials. The team will initiate
a dialogue with the FDA and prepare for a pre-Investigational New Drug (IND) discussion. Key milestones include
validating that the drug preserves fertility, demonstrating effective pain management with low doses, and
obtaining FDA guidance. Success in these areas will enable Sur180 Therapeutics to efﬁciently prepare for a
future market entry, capitalizing on previously approved safe drugs and securing market exclusivity. This will
ultimately improve patients' quality of life and reduce healthcare costs. The successful outcomes of this project
represent a signiﬁcant advancement in providing a long-lasting, disease-modifying solution for millions of women
worldwide.

Public health relevance
PROJECT NARRATIVE Novel therapeutics for endometriosis are urgently needed to improve the health-related quality of life, work productivity, and mental health of millions of patients worldwide. Due to its complex nature, lack of effective treatments, and delayed diagnosis, endometriosis leads to chronic and painful symptoms, including pelvic pain and infertility, creating a substantial burden on healthcare systems and society. We propose commercializing corticotrophin-releasing hormone receptor antagonists to treat endometriosis, which we showed produces long- lasting pain suppression and disease-modifying properties without deleterious effects in mood and bone density, a vast improvement to current therapeutic options. Providing women with endometriosis with a drug that they can take long-term to medically manage pain and other associated symptoms will significantly improve clinical and mental health outcomes and reduce healthcare spending.